Genetic Susceptibility And The Environment In Cancer Risk

Over the past year as part of several international consortia on breast cancer genetic susceptibility we have published more than 10 papers, including publications in the New England Journal of Medicine, Nature Genetics, Nature Communications, Journal of Clinical Oncology, The American Journal of Human Genetics. These publications have focused on a variety of subjects critical to public health, including the identification of new common polymorphisms associated with breast cancer, redefining the set of rare high-penetrance inherited mutations associated with breast cancer, examining how low and high penetrance variants combine to affect a women's risk of disease and whether these risks continue late into life, and identifying specific gene variants and predictors of risk for African American women. We have carried out similar genetic studies of prostate cancer risk where we have examined trans-ancestry risks associated with specific alleles and published two studies identifying risk alleles in African American men.